Measuring pregnancy preferences among women and men in a resource-limited, high-fertility setting

PROJECT SUMMARY/ABSTRACT
Our goal is to improve measurement of women’s and men’s prospective pregnancy preferences
in low-resource, high-fertility settings in sub-Saharan Africa through gender-specific evaluation
and adaptation of the Desire to Avoid Pregnancy (DAP) scale (Aim 1) and assess the reliability
and validity of adapted DAP scales through testing among women and men in Uganda (Aim 2).
Our team of experts in qualitative methods, scale development, and survey research from the
United States and Uganda will conduct a sequential mixed-methods study to understand
transferability of DAP domains among Ugandan women and men, adapt and develop items that
reflect their perspectives, and pilot test and psychometrically evaluate items. Specific aims are to:
1. Aim 1: Develop gender-specific versions of the Desire to Avoid Pregnancy (DAP)
scale that have construct validity among women and men, respectively, in the
Ugandan context. We will translate the DAP scale items into local languages and use
qualitative methods, including cognitive and in-depth interviews, among 30 women aged
15-49 and 30 men aged 18+ years to explore item comprehension and salience of DAP
domains. We will use deductive, thematic analysis to examine convergence and
divergence of women’s and men’s pregnancy preferences, respectively, with each DAP
domain and adapt DAP items to capture pregnancy preferences in the Ugandan context.
2. Aim 2: Evaluate the reliability and validity of the Ugandan DAP scales. We will
purposively sample 400 women aged 15-49 years and 400 men aged 18+ years in one
rural and one urban district to conduct face validity and pilot testing of the adapted DAP
scales. We will analyze the psychometric properties of the DAP scales, including
dimensionality, internal consistency reliability, and structure validity, separately for men
and women, using methodologies grounded in Item Response Theory.
The development and validation of the adapted DAP scales will improve the capacity of
health programs in low-resource, high-fertility contexts to (i) identify individuals with strong
desires to avoid pregnancy, (ii) tailor person-centered reproductive services to meet their needs,
(iii) strengthen understanding of the dynamics of pregnancy preferences within couples, and (iv)
enhance the utility that measures of pregnancy preferences offer for predicting and addressing
fertility, maternal, and child health outcomes to promote lifelong health and well-being.

Public health relevance
PROJECT NARRATIVE Pregnancy preferences are a key indication of an individual’s reproductive health needs, intentions, and desires, yet the measurement of this concept has been limited by a lack of rigorously evaluated metrics, particularly in resource-limited, high-fertility contexts. Public health efforts to prevent unintended pregnancy in settings like Uganda, where many women’s fertility intentions are at odds with their contraceptive practices, are hindered by metrics that fail to capture the multidimensionality of pregnancy perspectives, including the influence of male partners in these decisions. The proposed research will improve gender-specific measurement of pregnancy preferences and create psychometrically valid measures, relevant for women and men in resource-limited, high-fertility contexts, to inform strategies for reducing unintended pregnancy and improving person-centered reproductive health services that support reproductive autonomy.